Targeting Neuropathogenesis of Altered Mental Status to Improve Survival in Cryptococcal Meningitis

Project Summary / Abstract
Dr. Mahsa Abassi is an Assistant Professor of Medicine in the Division of Infectious Diseases at the
University of Minnesota. Over the past six years, she has been engaged in clinical research, focusing on HIV-
related neuroinfections in Uganda. Her long-term objective is to become an independent clinical researcher
with an emphasis on improving outcomes in neuroinfections. Her career development plan proposes mentored
training in: 1) neurologic techniques (EEGs, neuroradiology, and neurocognitive assessment), 2) laboratory
techniques related to metabolomics applications, and 4) biostatistics with an emphasis of analyzing
metabolites in biologic samples.
Research: Cryptococcal meningitis accounts for 15% of HIV/AIDS-related deaths globally and is the most
common cause of adult meningitis in Africa. Altered mental status (ranging from delirium to coma) at the time
of cryptococcal meningitis diagnosis is consistently an independent predictor of increased mortality. Despite
repeated studies confirming this strong association between altered mental status and death, there is a
fundamental lack of understanding into the exact neurological abnormalities leading to acute altered mental
status, its contributions to increased mortality, and the best practices for management.
The objective of this proposal is to identify the neurological abnormalities that contribute to altered mental
status and to understand how this contributes to increased cryptococcal mortality. The overarching hypothesis
is that cryptococcal meningitis with its increased intracranial pressure leads to cerebral hypoxia, abnormal
electrical activity, and biochemical changes in the central nervous system (CNS) that can be detected through
brain metabolite CSF analysis and enhanced clinical monitoring with cerebral oximetry and EEGs. This
proposal aims to: 1) determine if HIV-infected persons with cryptococcal meningitis presenting with altered
mental status (Glasgow Coma Scale (GCS) <15) at diagnosis have measurable underlying neurological
abnormalities and impairments in cerebral energy metabolism (i.e. insufficient oxidative metabolism) as
compared to persons with normal mental status (GCS=15); and 2) determine if implementation of standardized
clinical interventions can reverse neurological abnormalities and improve cerebral energy metabolism within 3
days of diagnosis, and reduce 30-day mortality in HIV-infected persons with cryptococcal meningitis presenting
with altered mental status (GCS<15). Results of the above aims will shed light into previously unknown
pathophysiologic mechanisms that lead to altered mental status in cryptococcal meningitis. The training in
neuroinfections, metabolomics applications, and biostatistics that Dr. Abassi will obtain will inform future
proposals dedicated to understanding the neuropathology of various neuroinfections and finding evidence-
based interventions dedicated to improving survival.

Public health relevance
Project Narrative In HIV-associated cryptococcal meningitis, altered mental status is a common clinical manifestation and is associated with a significant increase in mortality. There is a considerable lack of understanding as to the exact neurological abnormalities leading to the development of acute altered mental status in cryptococcal meningitis. The objective of this study is to identify the underlying neurological abnormalities that result in the development of altered mental status during cryptococcal meningitis and to identify clinical interventions to reverse these neurological abnormalities and improve survival.